CRYSTAL STRUCTURE STUDIES OF ORNITHINE DECARBOXYLASE ODC1

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. ODC1, ornithine decarboxylase 1, is usually dysregulated in cancer cells. Inhibition of ODC1 is important for cancer treatment. The focus of current project is to determine the crystals structure of ODC1 complexed with inhibitor that we identified.